Epitranscriptomic Markers in Microbiome-Derived Cell-Free RNA from Plasma for Colorectal Cancer Diagnosis

PROJECT SUMMARY
Circulating cell-free DNA (cfDNA) and RNA (cfRNA) offer enormous potential as a new class of biomarkers for
developing non-invasive liquid biopsies applicable to numerous diseases and conditions. Recent years have
seen intense study of cfDNA and cfRNA as tools for non-invasive prenatal testing, solid organ transplantation,
cancer screening, and tumor monitoring. However, early cancer detection has been hindered by the low
concentration of tumor-derived cfDNA in plasma, resulting in decreased sensitivity and specificity. While
epigenetic-based cfDNA sequencing approaches have been developed; however, their effectiveness remains
limited by the low abundance of target analyte at early stages. Cell-free RNA (cfRNA) presents a promising
alternative, yet its practical application of cfRNA faces hurdles: rapid degradation of cell-free mRNA, insufficient
quantities in clinical samples, and cellular contamination altering mRNA levels, thus compromising the detection
specificity. Moreover, the study of epitranscriptomic markers from cfRNA remains challenging due to the lack of
robust sequencing methods. To address these critical knowledge gaps, this project aims to (i) profile the
transcriptomics and epitranscriptomics of plasma cfRNA, (ii) develop epitranscriptomic patterns for microbiome-
derivative cfRNA as biomarkers for colorectal cancer (CRC) diagnosis. As described in the preliminary data in
this application, I have developed an innovative method called "Low-Input Multiple MEthylation Sequencing"
(LIME-seq) to monitor abundance and site-specific modifications across multiple RNA species from ultra-low-
input cfRNA (sourced from only 600 μL plasma). Applying this method to human plasma samples, I have
successfully uncovered the presence of tRNAs and specific ncRNAs as major cfRNA components originating
from both human and microbiome sources. Importantly, I discovered that methylation patterns in microbiome-
derived cfRNA represent an effective class of non-invasive biomarkers with unprecedented potential for early
CRC diagnosis, offering a distinct advantage over microbial abundance profiles obtained from cfRNA/cfDNA
sequences. These methylation patterns accurately reflect microbiota activity, surpassing traditional abundance-
based methods and providing a more prescise approach to study human microbiota. Leveraging the LIME-seq
technique, I will conduct a comparative analysis between the transcriptomic and epitranscriptomic landscapes
of specific microbiomes and that of plasma cfRNA. This will validate the presence of certain microbiome-derived
cfRNA and confirm the RNA methylation sites. I will also demonstrate the utility of microbiome-derived cfRNA
profiles sourced from plasmain CRC diagnosis, with a particular focus on adenoma and stage I. The projected
outcomes of this study will generate both diagnostic and predictive biomarkers from methylation sites of
microbiome-derived cfRNA and provide a non-invasive method for assessing microbiota. Furthermore, a more
ambitious vision for this research could be to identify novel microbiome targets, which could become potential
therapeutic strategies for CRC prevention and treatment.

Public health relevance
PROJECT NARRATIVE Circulating cell-free RNA (cfRNA) in human plasma, derived from both human and microbiome sources, carries site-specific RNA modifications that show promising potential for non-invasive disease diagnosis and prognosis; however, detecting these RNA modifications, especially in cell-free RNA that majorly constitute by small RNA, remains challenging due to the low amount. This proposal aims to characterize RNA modifications in cfRNA, with a particular focus on microbiome-derived cfRNA from plasma, and assess their potential as reliable and powerful biomarkers for monitoring microbiota activity in the context of colorectal cancer diagnosis. Through this innovative research, we anticipate two primary outcomes: (i) comprehensive profiles of both transcriptomics and epitranscriptomics in human plasma cfRNA originating from both host and microbiome sources, and (ii) development of robust diagnostic and predictive epitranscriptomic biomarkers in microbiome-derived cfRNA for colorectal cancer, potentially revolutionizing early detection and treatment strategies.